Improving Screening for Second Primary Lung Cancer in High-Risk Veterans

Background: Meeting the unique medical needs of cancer survivors – set to rise from 18 million currently to
26 million in the US by 2040 – presents a growing challenge for the Veterans Affairs (VA) system. Lung cancer,
the second most common diagnosis at the VA, is expected to accelerate this growth, driven by increased
screening uptake and advances in treatment. Significance: Lung cancer survivors who develop second
primary lung cancer, a new cancer distinct from recurrence, experience twice the mortality of those who do not,
stressing the need for surveillance protocols for early detection. While established lung cancer risk factors,
such as smoking, impact the risk of second cancers, current guidelines on screening for survivors exclude
these factors. Lacking clear guidelines, both over- and underscreening may occur. Underscreening may miss
early second cancer diagnoses, while overscreening risks radiation exposure and unnecessary biopsies.
Screening based on individual risk can minimize harms (false positives) while maximizing benefits (true
positives). While we've previously developed and validated a risk prediction model for second primary lung
cancer in non-Veterans, the unique risks of Veterans necessitate a new, tailored model. Also, before starting a
trial of risk-stratified screening, we need a feasible intervention to ensure that screening effectiveness is not
limited by uptake. Here we aim to develop a Veteran-specific risk model and adapt existing risk stratification
interventions in initial primary lung cancer screening to second primaries. Innovation & Impact: Our study will
be the first to develop and pilot a risk stratification intervention for second primary lung cancer screening in
clinic. This work will set the stage for an IIR application for a future multi-site Hybrid III trial, evaluating the
implementation and effectiveness of risk-stratified screening on survivor outcomes and ultimately improve
survivor mortality. Specific Aims: Aim 1: Develop and validate a Veteran-specific second primary lung cancer
risk prediction model and assess its potential benefit over current guideline recommendations. The objective is
to develop a comprehensive risk model and evaluate the net benefit of using the risk model to guide screening.
Aim 2: Understand key stakeholder perspectives on current screening workflows to inform the future
incorporation of risk-stratified screening for survivors. The objective is to identify barriers and facilitators to the
proposed risk stratification intervention in current initial and second primary lung cancer screening workflows.
Aim 3: Develop and pilot modifications of existing lung cancer screening workflows to optimize screening for
Veteran survivors at high risk of second primary lung cancer. Using the risk model from Aim 1 and stakeholder
insights from Aim 2, the objective is to develop and pilot a risk-stratification intervention for screening survivors.
Methodology: In Aim 1, we will develop a second primary lung cancer risk prediction model using electronic
health record data, incorporating known lung cancer risk factors and cancer-specific information from the VA
Cancer Registry. We will validate the model and evaluate the impact of risk-stratified screening on the balance
between true and false positives (net benefit) compared to current guidelines. In Aim 2, we will interview clinical
providers and screening coordinators on A) risk stratified screening for initial primary cancer and B) survivor
imaging workflows to adapt initial primary risk stratification interventions to meet survivor needs. In Aim 3, we
will design and pilot the risk stratified survivor screening intervention and intervention strategies. We will
iteratively adapt our strategies to local needs at each individual pilot site. Upon completing the pilot, we'll
interview site staff to assess acceptability and identify strategies to address potential barriers to scaling the
intervention. Next Steps/Implementation: This Career Development Award lays the groundwork for my career
as an independent VA investigator focused on implementing risk models in clinical practice to improve cancer
care. This research represents a pioneering effort to redefine survivor care through innovative risk-stratified
interventions, with potential for broader application across other cancers and survivor-related health concerns.

Public health relevance
Meeting the unique needs of the growing population of cancer survivors is a critical challenge for all healthcare systems. With increasing screening uptake and advances in treatment, lung cancer, the second most common cancer at the VA, will significantly contribute to the demand for survivorship care. Lung cancer survivors are at increased risk of dying from second primary lung cancer, necessitating effective survivor screening strategies. However, current survivor screening guidelines overlook individual variations in cancer risk, potentially leading to both over- and underscreening. We aim to extend risk-stratified screening, currently used for initial primary lung cancer, to second primary lung cancer, customizing it for survivor-specific risks and care teams. Our work directly aligns with the VA Lung Precision Oncology Program’s goal to “prioritize screening to identify early- stage lung cancer in high-risk Veterans.” This work will contribute towards the goal of improved survivorship care set forth by the White House Cancer Moonshot Initiatives and VA National Oncology Program.